Pre-doctoral Training in Fundamental Approaches to Biochemistry and Cell and Molecular Biology

Enter the text here that is the new abstract information for your application. This section must be no longer than 30 lines of text.
This proposal is for support of the pre-doctoral program in Cellular, Biochemical and Molecular Science at the Massachusetts Institute of Technology (MIT). Our mission is to train the next generation of biological/biomedical scientists, many of whom will be innovators and leaders in research, education, and other fields. This proposal builds on an outstanding training record developed over a 46-year partnership with NIGMS. Our aims are to: educate students to understand the fundamental and underlying principles of molecular, biochemical, and cellular biology, train students to be critical and creative thinkers, prepare students to be ethical decision makers, teach and provide practice in written and oral communication, provide experience with teaching and mentoring younger students, mentor students to become effective and rigorous researchers, guide students through completion and publication of research projects, advise students as they determine best-fit careers based on their individual interests and skills, provide a comprehensive learning and research environment, and ensure participation in biomedical research careers. Trainees admitted to our program have outstanding academic records and strong motivation and aptitude to pursue research. A key feature of our program is an intensive, focused curriculum required of all first-year students. Students work together in lecture and discussion-style courses taught by dedicated faculty to master a fundamental set of approaches that underpin molecular biological science. The training program exposes students to the research interests of all faculty members in the Biology Department prior to a sequence of rotations that, in combination with first-semester courses, support an informed choice of a thesis advisor and topic. Students gain experience in scientific communication and in teaching and mentoring junior students. Responsible conduct of research is taught in both classroom and laboratory settings, including an intense mini-course for 2nd year students. Students have many opportunities to learn about career paths open to them following doctoral training. Students’ progress through the program is monitored in regular thesis committee meetings with faculty members, with oversight by the graduate committee. We seek to build and maintain a welcoming and supportive learning community. This training grant would constitute a critical source of support for ~50% of training-grant eligible graduate students in our program during their first two years. Our students perform research of outstanding quality, and most trainees go on to careers in biomedical research. Many of our former trainees are now leaders in their chosen fields and bring to their positions the knowledge, rigor, and thoughtful perspectives that we emphasize at MIT Biology. We anticipate exciting futures for our alumni as they help transform the US biomedical landscape.

Public health relevance
The MIT Department of Biology trains some of the world’s most talented young scientists to unravel cellular and molecular complexities fundamental to human health and disease. Our program provides training in the foundational approaches to biological research and a deep research experience in a student’s chosen area. We also educate students about the basis of ethical and humane decision-making and prepare them for leadership positions in a range of biomedical careers.